Rhythmic pace-making of nephron induction for renal replacement tissues

PROJECT SUMMARY
The goal of this proposal is to study and control rhythmic nephron induction for kidney replacement
tissues. Kidney organoids derived from human induced pluripotent stem cells (iPSCs) re-create an astonishing
cellular diversity comparable to the early fetal kidney. However, barriers remain to their implementation for
regenerative medicine, chiefly the staggering volume of properly ‘plumbed’ tissue that would be necessary for
functional replacement. This creates an urgent need to achieve scale-up of nephron generation. The kidney
achieves scale-up during its development through an exponential increase in the number of nephron-forming
‘niches’ associated with the branching tips of the future urinary collecting duct tree. However, organoids generate
nephrons in a single wave, failing to capture rhythmic, exponential nephron production from self-sustaining
niches. Our long-term goal is to construct ‘higher-order’ synthetic kidney tissues using human stem cell, cell
engineering, and assembly technologies that mimic the outcomes of morphogenesis. Our overall objective here
is to gain temporal control over rhythmic nephron formation. Achieving this will mark a transformative advance
toward creating replacement kidney tissue and in fundamental understanding of low nephron endowment, a risk
factor for hypertension and chronic kidney disease. Our central hypothesis is that the periodic avalanche-like
commitment of nephron progenitors to new nephrons is governed by a rhythmic ‘pace-maker’ across several
signaling pathways. We plan to achieve our objective through two specific aims. Firstly, we will determine
pace-making coordination across cell types in the mouse nephrogenic niche. We will expand from our
preliminary spatial RNA sequencing data that discovered rhythmic alternating phases of nephron progenitor
differentiation and renewal in each niche. This will define a spatiotemporally resolved map of cell-cell interactions
contributing to nephrogenesis pace-making. Second, we will synthetically engineer pace-making and the
nephrogenesis chain-reaction in human iPSC-derived organoids. We will program rhythmic nephrogenesis
in iPSC-derived nephron progenitors using optogenetics technology and by leveraging intrinsic molecular clock
dynamics. The proposed research is innovative because we co-opt our discovery of cyclical nephrogenesis
signaling for novel engineering control strategies, while creating tissues that are compatible with patient-derived
autologous cells for future transplantation. The proposed research will have significant positive impact in two
areas: 1) Scale-up of human kidney tissue will create a step-change in renal replacement technology beyond
dialysis, transplant, and “abiotic” filtration. 2) New discoveries in rhythmic nephron patterning will inform
actionable approaches to improve persistence of nephrogenesis and increase nephron endowment in neonates.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will study and engineer new principles of organ development toward building functional human tissue models. Once these new principles are applied, they will spur significant advances in tissue engineering for regenerative medicine. The proposed research is especially relevant to one of the NIH’s 2021-2025 strategic plan goals, which specifically highlights new cell engineering and bioengineering approaches to building human tissues for disease modeling that will contribute to reducing illness and disability.